Reaching Optimal Implementation and Mental Health Outcomes for Underserved and Rural Communities in Foster and Kinship Care: Adaptation and Evaluation of the KEEP Model

PROJECT SUMMARY
There are alarming disparities in the prevalence of mental health (MH) disorders and suicide between youth
with a history of child welfare system (CWS) and their non-CWS-involved peers. Yet few services are designed
for these high-risk youth, and even fewer focus on racial and ethnic, and sexual and gender minority (SGM)
populations, which bear a disproportionate proportion of the burden of MH disorders and are overrepresented
in the CWS. Also underserved in the CWS are rural populations for which few services exist. “Keeping Foster
and Kinship Parents Supported and Trained” (KEEP) is an evidence-based intervention that focuses on
optimizing the role of foster/kin parents as the agents of positive change for children and youth. The proposed
application capitalizes on a current contract with the Oregon Department of Human Services Child Welfare to
implement KEEP state wide in Oregon with a focus on increasing access to services for rural and minority
youth populations. To help the CWS meet their goal of achieving health equity, adaptations to the KEEP
curriculum have been made for minority groups, and KEEP is being delivered in “affinity groups”. Affinity KEEP
(A-KEEP) groups are tailored to meet a specific population’s needs and are comprised of parents who all share
a common interest, purpose, or key characteristic. To date, A-KEEP groups are being offered for foster/kin
parents of populations defined by SGM youth and Native youth, and for Spanish-speaking parents. The
curriculum is currently being revised for transracial foster/kin placements where Black/African American youth
are placed in homes with one or more White parents. KEEP groups are also offered via web conference for
rural foster/kin parents. The current proposal seeks to study N = 500 new families (53% rural and 15% A-
KEEP), as part of the ongoing Oregon KEEP implementation, and aggregate existing data from four KEEP
studies (N = 2,397) to use propensity score matching to reduce selection bias and strengthen causal
inferences that can be drawn from the potential benefits of providing KEEP to underserved rural and minority
populations. By leveraging two decades worth of data on the KEEP intervention and using state-of-the-art data
harmonization techniques and a quasi-experimental design, this study affords a rigorous evaluation of whether
tailoring the KEEP curriculum to minority populations’ specific needs, and providing KEEP to rural foster/kin
parents, improves youth MH outcomes (i.e., depression/anxiety, PTSD symptoms, suicidality, and externalizing
behaviors) (Aim 1), maximizes uptake and dosage, and improves parenting factors (Aim 2). Further, whether
such improvements are mechanisms of action explaining the positive impacts of the intervention on youth MH
will be examined (Aim 3), as well as the optimal dosage necessary to improve youth MH outcomes (Aim 4).
The proposed study could have a wide reach, impacting our understanding of how to improve and inform
equitable delivery of services to youth and families involved in the CWS, and effectively address youth MH
disorders and improve care quality and long-term outcomes for a high-risk, underserved population of youth.

Public health relevance
PROJECT NARRATIVE There are alarming disparities in the prevalence of mental health disorders and suicide between youth with a history of child welfare system and their peers with no such histories. This study capitalizes on an opportunity to formally evaluate local adaptations of “Keeping Foster and Kinship Parents Supported and Trained” (KEEP), an evidence-based foster parent intervention, to reduce mental health disparities among child welfare-involved youth and improve care quality and long-term outcomes for rural, Native, Hispanic/Latino, Black/African American, and sexual and gender minority youth. The knowledge gained from the study will impact all current and future large-scale implementations of KEEP and will bolster our scientific understanding of the mechanisms of action for interventions and the optimal dosage necessary to improve youth mental health outcomes for an underserved, high-risk population of youth from a real-world child welfare-intervention context.